Staffing and Health Outcomes in Nursing Homes for Residents with and without Dementia

PROJECT SUMMARY/ABSTRACT
Nurse staffing – registered nurses, licensed practical nurses, and certified nurses’ assistants – have long
been considered an important factor determining the quality of care that nursing home residents receive and
their health outcomes. Information about nurse staffing levels are included in Nursing Home Compare (NHC),
the report card published by the Centers for Medicare & Medicaid Services (CMS) as one of the three 5 Star
sub-measures, as well as the overall 5-Star measure. Many states and the Federal Government have
established minimum staffing standards for nursing homes. These attest to the importance that policy makers,
experts, advocates, and residents place on staffing, as both determinants and indicators of quality.
With the increasing prevalence of Alzheimer’s disease and related dementias (ADRD), nursing homes are
facing an increasing population of residents with dementia (RWD). These residents are expected to require
even higher staffing levels, compared with residents without ADRD. Yet, the information about, and our
understanding of the needs for staffing other than nursing, such as therapists and social workers, and
specifically how nurse staffing and other professional staff influence health outcomes for RWD is lacking. The
objective of this proposal is 1) to address this gap in knowledge; and 2) to assess the impact of the projected
increase in RWD in nursing homes on workforce requirements. This has been identified as an important policy
objective, as indicated in the National Institute on Aging’s Research Milestone 13.J.
The specific aims of the application are: 1) To apply econometric techniques to administrative data to
estimate the effects of short- and long-term variations in nursing, therapy and social work staffing levels to
several short- and long-term outcome measures for nursing homes treating a small percent and a large
percent of RWD, and to assess the incremental staffing requirement by staff type and health outcome required
in nursing homes with a high population of RWD compared with nursing homes with a low population of RWD;
2) To determine the implications of the findings for nursing homes and for local, state and national labor
markets based on projected prevalence of RWD in nursing homes; and 3) To develop a web-based application
for policy and decision makers based on our findings, which would allow them to test the impact of different
ADRD and RWD growth scenarios and staffing standards policies on workforce predictions at the nursing
home and market level.

Public health relevance
PROJECT NARRATIVE This project will contribute to knowledge about the relationships between staffing levels of registered nurses (RNs), licensed practical nurses (LPNs), certified nurse assistants (CNAs), physical therapists, occupational therapists, speech-language pathologists (i.e. speech therapists), and social workers, and several outcomes for residents in nursing homes, including deficiencies. It will provide information for both nursing homes that treat large populations of residents with Alzheimer’s disease and related dementias (ADRD) and nursing homes with few residents with ADRD. This information will enhance the ability of policy makers at all levels to plan and develop policies that will improve workforce planning and allocation and ultimately will improve outcomes for residents with ADRD.